The Role of Ceramides in the Intestinal Stem Cell

SUMMARY
Exposing cells to excessive amounts of lipid and other nutrients promotes the accumulation of sphingolipids such
as ceramides, which alter tissue metabolism to help cells adapt to the abundance of excessive, detergent-like
fatty acids (Chaurasia et al., Science, 2019). Studies described herein reveal that ceramides play particularly
prominent roles in the gastrointestinal tract, where they increase fatty acid uptake into intestinal stem cells to
promote regeneration of the intestinal epithelium. Using organoid, fly, and mouse models, we will dissect the
mechanisms linking these sphingolipids to the control of intestinal stem cell metabolism, proliferation, and
differentiation. Moreover, we will explore the contribution of sphingolipids as signals of lipid excess that drive
gastrointestinal tumorigenesis and invasiveness. Findings obtained from these studies could uncover new
nutrient-sensing machinery that modulates intestinal stem cell proliferation and leads to new pharmacological
approaches for manipulating sphingolipids to improve gut health.

Public health relevance
NARRATIVE Ceramides are products of fat and protein metabolism that accumulate in individuals with obesity or dyslipidemia. Herein we investigate their contribution to cancers in the gastrointestinal tract by dissecting their impact on the ability of intestinal stem cells to use nutrients and proliferate. The work could uncover new therapeutic approaches for combating gastrointestinal cancers associated with obesity.